Consequences of social isolation during the COVID-19 pandemic in older adults with and without Alzheimer's disease

The COVID-19 pandemic has caused over half a million deaths in the United States alone. Even for
those individuals whose physical health and financial security have not been impacted, the
consequences of pandemic-induced isolation on mental and cognitive health may be far-reaching—
especially for our Veterans. Prior to the pandemic, approximately 10% of older Veterans reported
feeling lonely often and 40% indicated feeling lonely some of the time. Due to social distancing
guidelines and other measures that limit social contact, loneliness during the pandemic has likely
been far greater than these estimates. Decades of research have supported the protective effect of
social relationships on cognition in older adulthood; thus, the disruption of social support related to
the pandemic may impact cognitive function in the older Veteran population. To address this
possibility, we propose a prospective study to examine the relationships between isolation in the
pandemic and subsequent cognitive function in healthy older adult Veterans and in older Veterans
with Alzheimer’s disease (AD) (Aim 1). In addition, forced isolation is likely not the only factor with
important consequences in the pandemic. We propose investigating two other pandemic-related
contexts that may either mitigate the effects of isolation in the pandemic or exacerbate the
consequences of cognitive impairment on health-related outcomes for older Veterans. First, older
Veterans may be able to cope with isolation through use of features of the built environment, such as
porches, window views, and public neighborhood space. However, the extent the built environment
may be able to mitigate pandemic-related loneliness in older adults is unknown. In Aim 2, we test the
hypothesis that built environment factors will mitigate or contribute to social isolation in older Veterans
with and without AD. In addition, individuals’ cognition may be impacted by their belief in
misconceptions related to social isolation itself. In Aim 3, we test the relationship between cognitive
function and the ability to correct misconceptions related to social isolation and AD—and whether
such corrections engender changes in behavior. To accomplish Aims 1-3, we will apply
questionnaires and neuropsychological tests administered during the first wave of the pandemic
(June 2020-June 2021) to 196 participants over three additional one-year time intervals from October
2022 to September 2025. In Aim 1, we will test the relationship between social isolation in the
pandemic and cognitive function one, two, and three years later. In Aim 2, we will test whether older
Veterans with fewer built environment resources will demonstrate a worsening of social isolation,
loneliness, depression, anxiety, and cognition over time. In Aim 3, two objectives will be tested. First,
we will determine the extent that individuals with and without cognitive impairment due to AD can
successfully change their belief in misconceptions related to social isolation and AD through a
correction procedure over time. Second, we will test whether corrections related to changes in
behavior at delayed intervals of 1 and 2 years. Preliminary cross-sectional data from our already
recruited final sample of older adults (N=196) with and without AD support the relationships between
social isolation and cognitive impairment (Aim 1), the built environment and social isolation (Aim 2),
and cognitive impairment and misconception correction (Aim 3). As the ramifications of the pandemic
continue to unfold for years—possibly decades—it is imperative that we understand the relationship
between social isolation and future cognitive impairment in Veterans with and without Alzheimer’s
disease.

Public health relevance
Due to the COVID-19 pandemic, social distancing guidelines have recommended that individuals stay at home and limit noncritical social contact, which has led to increased feelings of loneliness and social isolation—especially amongst older Veterans. Importantly, social isolation is considered a risk factor for Alzheimer’s disease dementia and may carry consequences for cognitive function. The goal of this grant is to analyze how the pandemic has and continues to engender social and emotional factors that contribute to cognitive decline over time to better understand the long-term effects of the COVID-19 pandemic in older Veterans with and without Alzheimer’s disease, as well as techniques that can be leveraged to correct misconceptions related to social isolation and health. Understanding these complex relationships represents the first step in designing effective interventions to improve the lives of our older Veterans, including those with Alzheimer’s disease.